EFFICACY OF INHIBITION OF GASTRIC ACID SECRETION BY INTRAVENOUS PANTO

The object of this study is to identify and to evaluate the safety of intravenously administered pantoprazole that would decrease and maintain acid secretion at less than 10 mEq/hr in patients with Zollinger-Ellison syndrome with or without multiple endocrine neoplasia type I (MEN-I) syndrome who have not undergone partial gastrectomy (<5 mEq/hr in patients with previous gastric surgery) Study terminated October 1998. Data is being analyzed.